Botswana-UPenn: Research Consortium of HPV-Related Cervical Cancer in HIV Patient

Abstract:
The cervical cancer burden in low and middle income countries make up about 80% of the total cervical
cancer incidence worldwide. In Botswana the link between increased incidences of cervical cancer in
HIV positive women has not been carefully explored. Furthermore there is an increased link between
infectious disease and cancer as seen by additional recent studies including the presence of Merkel Cell
Carcinomas with Merkel Cell Polyoma virus. This underscores the importance of these agents and their
contributions to the oncogenic process. Greater than 20% of human cancers are associated with
infectious agents and that estimate is likely to be lower than the actual number. The advances in
technology and approaches which include recovery of nucleic acids from tissues and other materials has
greatly improved our ability to detect and confirm the identifications of these agents in associated cancers.
The overall goal of the proposed studies in project #1 is to determine the contributions of infectious agents
to development of cervical carcinomas in HIV positive women in Botswana. This dramatic increase in
cervical cancer incidence in HIV positive women in Botswana allows for the potential contributions of
additional agents as well as the inflammatory response which together leads to a more rapid and
proliferative response. Our project will take advantage of our unique cohorts of women in Bostwana that
allows us to monitor changes in the cervical flora from HPV and HIV negative women to women with
cervical cancer who are HIV and HPV positive. Our initial question will be to identify additional agents
which may be linked to development of cervical carcinomas in this population. Our working hypothesis is
that multiple agents can contribute to the development of cervical carcinomas in HIV positive women in
Botswana and this can result in an inflammatory response which synergistically leads to cervical
carcinomas. We will utilize our newly developed combinatorial strategy which bridges microarray
technology with high throughput sequencing. The identification of these agents will be followed by
validation of the presence of these agents in tissues, transcription analysis of infected cells as well as
analysis of the innate and adaptive inflammatory responses with the associated agents, and investigating
the proliferative effects on these cells.

Public health relevance
Narrative HPV is one of the major causative agents to development of cervical cancer in high risk patients, and the burden of HIV is as high as 40% so leading to increased incidence of cervical cancer, an AIDS-defining cancer. The proposed consortium studies will explore, the natural history and pathogenesis of HPV in HIV positive women in Botswana and develop treatment and prevention paradigms based on our discoveries. Our goal is to reduce the burden of cervical cancer in high risk women in Botswana.